CELLULAR MECHANISMS OF XENOBIOTIC TRANSPORT

The vertebrate renal proximal tubule mediates excretion of potentially toxic, charged organic compounds, e.g., metabolic wastes, environmental pollutants, drugs and their polar metabolites. Previous work which focussed on the separate mechanisms by which organic anions and cations cross the surface membranes of the renal tubular cells paid little attention to the routes by which these compounds traverse the cell interior, the assumption being that diffusion through the cytoplasm is the only process necessary. We are using comparative renal models (proximal tubules from lower vertebrates and invertebrates and mammalian cells in culture) combined with video imaging, fluorescence microscopy and intracellular microinjection to test that assumption. Our studies show that after organic anions enter renal cells they both diffuse through the cytoplasm and are taken u by vesicles. Sequestration in vesicles involves concentrative and specific uptake from the cytoplasm rather than endocytosis from the medium. These findings indicate that the intracellular distribution of organic anions is not uniform an that the cellular concentration measured in tracer uptake studies may overestimated cytoplasmic activity. In addition, they suggest that renal cells could use intracellular compartmentation to reduce levels of potentially toxic chemicals in the cytoplasm. Future studies will focus on: 1) defining the mechanisms and energetics of vesicular accumulation in renal cells, 2) determining the role of sequestration in overall organic anion secretion, 3) evaluating the possibility that sequestration underlies the extremely high levels of organic cations found proximal tubule cells, and 4) searching for intracellular sequestration mechanisms in other epithelia which accumulate and transport organic anions and cations, e.g., choroid plexus.